Mentoring Multidisciplinary Patient-Oriented Research in TB, HIV, and Global Health

Dr. Shah is a physician-scientist with 15 years of experience leading patient-oriented research (POR) on
diagnosis, treatment, and prevention of tuberculosis (TB) globally, including drug-resistant TB and TB/HIV co-
infection. Her experience with U.S. and international public health programs, including the Centers for Disease
Control & Prevention (CDC) where she trained and worked for a decade, provides a strong foundation for
integrating research into policy and patient care. This K24 award will allow her to enhance and expand her
successful mentorship in POR by providing vital protected time for training in advanced methods for studying
TB transmission, and developing a structured mentoring program. Worldwide, TB is the leading cause of death
among people living with HIV, with drug-resistant TB threatening decades of progress in TB and HIV control.
Drug-resistant TB epidemics are driven primarily by person-to-person transmission of resistant strains, and
innovative approaches to improve our understanding of TB transmission are urgently needed to guide effective
interventions. Similarly, there is a need to train the next generation of scientists in multidisciplinary TB/HIV and
global health POR. Dr. Shah’s robust research program supported by NIH, Gates Foundation, and CDC
provides exciting training opportunities that attract trainees interested in multidisciplinary TB & HIV POR. She
has a strong track record of mentorship of U.S. and international trainees in diverse areas of TB & HIV clinical
research, and many of her mentees have pursued academic careers and K awards. In addition, through her
role as Director of the Clinical Core for the NIH P30 Emory/Georgia TB Research Advancement Center and
mentor on D43 and T32 programs, she is well placed to provide outstanding research and training
opportunities. Biospecimens, clinical, and epidemiologic data from Dr. Shah’s ongoing NIH R01-funded
CONTEXT study provide new opportunities for insights into TB transmission, including the impact of the
COVID-19 pandemic on social contact patterns that are a key factor in disease spread. The CONTEXT study
will serve as the parent study for the new research proposed in this K24 that will: 1) characterize Mtb genomic
relatedness using long-read sequencing and evaluate the impact on transmission networks; and 2)
characterize changes in social contact patterns during the COVID-19 pandemic and estimate the impact on TB
incidence. Each aim is designed to integrate mentees who have experience and interest in growing their
careers in these emerging areas of TB transmission science. Dr. Shah’s research and mentoring program is
facilitated by her long-standing, cross-disciplinary collaborations with leading experts in mycobacterial
genomics, pharmacology, immunology, clinical trials, and mathematical modeling. In addition, the outstanding
training resources, funding opportunities, and research infrastructure at Emory will be integrated into Dr.
Shah’s mentoring program to create an environment that enables the success of her trainees to pursue
independent, impactful careers in TB, HIV, and global health POR.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is the leading cause of death among people with HIV, with drug-resistant TB threatening decades of progress in TB and HIV control. Dr. Sarita Shah is a physician-scientist at Emory University whose research spans clinical, translational, and public health studies to reduce the burden of TB & HIV globally. This K24 award builds on her long-standing commitment to mentorship in patient-oriented TB & HIV research and will provide vital protected time to 1) expand her mentoring program for physicians and scientists who are pursuing these fields, and 2) enhance her knowledge of epidemiologic and genomic methods to aid in the understanding of drug-resistant TB transmission and prevention.